Defining stress REsilience And Mindfulness Effects in Rheumatoid Arthritis (DREAMER) - admin supplement

PROJECT SUMMARY/ABSTRACT FROM PARENT GRANT
Rheumatoid arthritis (RA), the most common rheumatic disease, affects 1.5 million people in the United
States and can lead to debilitating joint pain, functional limitations, and premature mortality. Existing treatment
approaches based on immunosuppressive medications reduce disease severity but often fail to adequately
control symptoms and can lead to severe adverse side effects. This proposal addresses the critical unmet need
for non-pharmacologic strategies to augment medical management of RA, improve long-term clinical outcomes,
and reduce disease-related symptoms.
Psychological stress is postulated to exacerbate disease severity in autoimmune diseases, but few studies
have prospectively examined its impact on disease activity in RA patients or the therapeutic potential of
interventions that improve stress resilience in this patient group. Furthermore, while mindfulness-based
interventions (MBIs), including the mindfulness-based stress reduction program (MBSR), have been shown to
reduce psychological stress and pain in several chronic diseases, it remains unknown whether they represent
an effective adjunctive approach for improving disease outcomes in RA. To address these significant knowledge
gaps, I propose to examine the effects of stress, stress-buffering factors, and MBIs on risk of disease flares and
symptom severity in RA and related autoimmune conditions.
I will first identify mechanistic targets for mind-body interventions in RA by building on an actively enrolling
RO1-funded longitudinal cohort study of RA patients. Aim 1 will determine whether greater negative
psychological stress independently associates with increased risk of worse RA disease activity and symptom
severity over time. I will further test whether stress resilience and mindfulness longitudinally correlate with better
outcomes—including less severe disease activity and symptoms—to identify key targets for non-pharmacologic
interventions in this patient group. In Aim 2 I will develop augmentations to the mindfulness-based stress
reduction (MBSR) course for people with inflammatory arthritis, and conduct a pilot study to assess the feasibility
and acceptability of an MBSR trial for improving disease outcomes in RA.
This will be the first longitudinal study to examine the effects of psychological stress and stress resilience
on RA disease activity. Further, this study will advance the field of integrative rheumatology by developing
innovate methods to augment MBSR for people with immune-mediated inflammatory diseases. The proposed
study will generate proof-of-concept data to inform a subsequent randomized controlled trial with R-level
funding to test whether MBSR improves RA disease activity and symptoms. Importantly, this K23 Career
Development Award will catalyze my successful transition to an independent physician-scientist with an
impactful research program defining mechanisms and efficacy of MBIs in people with rheumatic conditions.

Public health relevance
PROJECT NARRATIVE FROM PARENT GRANT A critical need exists for non-pharmacologic interventions that improve outcomes in patients with chronic autoimmune conditions such as rheumatoid arthritis (RA). This study will leverage infrastructure and resources from an RO1-funded cohort to longitudinally examine the effects of psychological stress, stress resilience, and mindfulness on RA disease activity and symptom severity. These findings will provide mechanistic targets for mindfulness-based interventions in RA, and inform a pilot randomized controlled trial of mindfulness- based stress reduction (MBSR) for improving outcomes among people with chronic autoimmune conditions.